Disparities in emergency contraceptive metabolism dictate efficacy

Project Summary
Half the population will experience menstruation, is experiencing menstruation, or did experience menstruation.
Menstruation occurs for approximately a week each month for 40 years - a substantial amount of one’s lifetime
is spent menstruating. Menstrual health (cycle and menses length, regularity, and volume/flow) is a key
patient-reported outcome beyond its importance as a general indicator of health and fertility. Menstrual health
outcomes are not routinely included in clinical trials and have not been a consideration for vaccine trials.
Numerous reports of menstrual disturbances following COVID-19 vaccination, the complete absence of
evidence, and the lack of attention on this gender-specific issue contributes to vaccine hesitancy, causes
public mistrust and directly impacts preventable morbidity and mortality. Our preliminary data is the first
prospective population-level data to establish baselines for COVID-19 vaccine exposure (dose 1 and 2) and
menstrual-related outcomes. No other prospective population level dataset exists with regard to the impact of
any vaccine on the menstrual cycle.
Our large prospective cohort was established as part of a time limited NICHD supplement (R01HD089957 PI
Edelman) “COVID19 vaccination and Menstruation” which ended June 2022. The overall objective for this
application, in response to the Notice of Special Interest “ Emerging and Existing Issues of Coronavirus
Disease 2019 (COVID-19) Research Related to the Health and Well-Being of Women, Children and Individuals
with Physical and/or Intellectual Disabilities” (NOT-HD-22-002), is to continue utilizing our unique large cohort
to further understand the impact of COVID-19 vaccine exposure on the resolution of cycle disturbances 6
months post-vaccine, in key subpopulations like adolescents and contraceptive users, and with additional
doses of vaccine (‘boosters’). We have the datasets and access to additional data collection to expand our
analyses beyond our supplement grant aims. The continuation of the prospective data set also enables us to
rapidly respond to an ever-changing public health emergency. Our team has received the ongoing commitment
of two leading online menstrual cycle tracking platforms with the built-in user approval to provide this de-
identified data for research purposes plus the ability to survey these users to obtain additional data.

Public health relevance
Project Narrative Menstrual health is a key patient-reported outcome beyond its importance as a general indicator of health and the ability to get pregnant. The impact of vaccines on menstrual health is lacking. The proposed project is designed to build on our initial studies funded by a time-limited supplement and further understand the interaction between COVID-19 vaccines and the menstrual cycle in reproductive-age girls and women.